PRAVASTATIN ON CARDIAC RISK IN PATIENTS WITH DYSLIPIDEMIA AND DIABETES MELLITUS

Purposes of the study are (1) to assess the effect of pravastatin therapy on lipid levels, insulin levels, insulin resistance and glucose control; (2) to delineate the effect of pravastatin on metabolism of ldl and vldl; and (3) to assess the safety & tolerability of pravastatin in type ii non-insulin dependent diabetic patients.